Food Protection Task Force Conference for attendees from state, local, and privat

Response to Food Protection Task Force Conference Grant Program PA-09-123 Abstract The Tennessee Food Safety Task Force, represented and supported by partners in industry, federal, state, and local regulatory agencies and educational institutions, continues to lead efforts in Tennessee to enhance food safety and food defense by developing materials, holding tabletop exercises, and an annual food safety conference. The Task Force was initiated in 2002 and has been very successful. Task Force activities focus on issues at the state and local levels relating to various organizations and agencies and the roles and responsibilities they have related to food safety and food defense. The Task Force in Tennessee has engaged key stakeholders creating a network of members to address capacity and resource needs, outbreak coordination and investigations, information sharing and data collection, regulatory standards, communications and education, laboratory operations and coordination, and state and local training needs for epidemiology and outbreak investigations. Issues are addressed by stakeholders in face to face meetings and by conference calls as well as the annual food safety conference. The next conference entitled, The Future of Food Safety - Sorting Through the Food Safety Maze is scheduled to be held in Nashville, Tennessee on May 12, 2010. The conference includes speakers from FDA, CDC, and industry. With ongoing and enhanced FDA funding, we will continue Task Force activities including sponsorship of subcommittees, workshops, and annual conferences. Major benefits of the Taskforce include the routine interaction and networking of representatives from academia and industry with representatives from state, local, and federal government. Because foodborne disease remains a serious public health threat and a threat to food producers and suppliers, it is critical to maintain this project and sustain the Taskforce activities, including annual conferences. Plans for a 2011 conference include outreach to other regional Task Force groups and an evaluation of the Task Forces' best practices and projects.

Public health relevance
Public Health Relevance Statement A primary objective of the Food Safety Taskforce has been to lead efforts in Tennessee to enhance food safety and security by networking in Tennessee, developing materials, holding tabletop exercises, and an annual conference. Despite the successes of the Task Force and accomplishments to date, foodborne disease remains a serious public health threat and a threat to food producers and suppliers. __SpecificAimsTextDelimiter__ Face-to-face meetings have promoted frank discussion and allowed Task Force members to familiarize themselves with the roles of similar agencies and develop important working relationships with other members. In the event that the safety of the food supply in the state is compromised, agencies will not lose valuable time discerning whom to contact and which roles they will play. We feel this is a major benefit of the Task Force which will be maintained and enhanced with additional funding. Enhancements and updates to existing taskforce educational materials will promote the Task Force and objectives. Maintenance of the website and availability of presentations and educational materials is needed on an ongoing basis. Continued sponsorship of subcommittees, workshops and conferences allow Taskforce representatives from academia and industry to interact with representatives from state, local, and federal government. This collaboration and sharing of knowledge and experiences related to food safety and security is an important outcome of the Taskforce. The subcommittee charged with exploring and promoting the adoption of FDA Food Code in Tennessee is expected to bring a recommendation and assist in sponsoring legislation if deemed necessary. Completion of these projects will ultimately result in a better-integrated food safety system that maximizes the protection of the public health through early detection and containment of foodborne threats. The 2010 conference will build on the success of the previous conference, entitled, “Recall Initiation, Implementation, Effectiveness, and Costs: Enhancing Communication Between Industry, Regulators, and Public Health”, which was the best attended conference to date. All of the topics will expand or enhance food safety knowledge and response to foodborne outbreaks in Tennessee. The currently planned conference will bring in high-level speakers such as Michael Taylor (FDA) and Ian Williams (CDC) to discuss current food safety legislation and complexities in investigating national outbreaks. The panel speakers will cover microbiological sampling and the implications from the perspective of various key stakeholders. This is an extremely timely topic with the new FDA emphasis on environmental sampling. Preparations for the 2011 Tennessee Food Safety Taskforce Conference, which will be held at a location to be determined will begin after the conclusion of the 2010 conference May 12, 2010. Planning will include input from the TN Department of health, TN Department of Agriculture, University of Tennessee Agricultural Extension, and other appropriate agencies. The Task Force will reach out to other states with Task Forces in place or those considering formation of a Task Force to develop the agenda regarding best practices for state Task Forces.